Altered metabolism and machine learning for pancreatic cancer early detection

PROJECT SUMMARY
Pancreatic cancer is the 3rd leading cause of cancer death in the United States. The high mortality of
pancreatic ductal adenocarcinoma (PDAC) is largely a consequence of diagnosis at an advanced stage when
the tumor is no longer treatable for cure. Currently, asymptomatic screening for PDAC is not recommended for
the general population, with screening pursued only for a small subset of patients with pancreatic cystic lesions
or strong genetic risk for PDAC. Even when cancer is identified early, patients can have rapid recurrence after
surgical resection, most often with liver metastases. To improve outcomes for patients with PDAC, a number of
important advancements are urgently needed, including improved risk assessment to identify those at elevated
risk for PDAC, new non-invasive biomarkers to select individuals for intensive imaging surveillance, and better
strategies to identify those with localized tumors who are at risk for rapid recurrence after surgical resection. In
the current proposal, we directly address these critical areas of need, focusing on: (a) machine learning models
for risk assessment from electronic medical record data (Aim 1), (b) development of non-invasive biomarkers
from stool and computed tomography (CT) imaging that measure metabolic alterations caused by early PDAC
(Aim 2), and (c) characterization of CT imaging and circulating cell-free DNA methylation patterns to predict
presence of occult metastases at the time of surgical resection (Aim 3). Furthermore, we will collect and make
available clinical data, blood samples, stool samples, imaging studies, and tumor tissue from multiple patient
populations critical to PDAC early detection research, including those with early-stage PDAC, chronic
pancreatitis, genetic PDAC risk, pancreatic cystic lesions, and non-cancer controls (Aim 4). To accomplish the
proposed work, we have assembled a highly experienced and collaborative team that is fully committed to
working together and with other Pancreatic Cancer Detection Consortium units. Thus, we will leverage cutting-
edge machine learning approaches, develop multiple innovative, non-invasive biomarker technologies, and
collect a large array of data and clinical samples for collaborative activities within and outside the Pancreatic
Cancer Detection Consortium. With a highly dedicated expert team and clear scientific plan, we expect to
achieve our near-term goal of reducing pancreatic cancer mortality by finding PDAC earlier and treating it more
effectively for cure.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is a major cause of cancer death in the United States, largely due to diagnosis at a late stage in the majority of patients. We will pursue advancements in the critical areas of population-level risk assessment, non-invasive early pancreatic cancer biomarkers, and metastasis prediction through (1) machine learning models for risk assessment from electronic medical record data and imaging studies, (2) validation of biomarkers of metabolic dysfunction caused by early pancreatic tumors, and (3) characterization of imaging features and tissue-specific methylation patterns in circulating cell-free DNA that predict future metastases. Thus, we seek to reduce pancreatic cancer mortality at multiple stages by identifying high-risk individuals in the general population, using non-invasive biomarkers to select individuals who should undergo intensive surveillance, and predicting metastases in those with apparently localized pancreatic cancer.